MicroRNA lipid-nanoparticle based therapy targets neuroinflammation and ApoE dysregulation in Alzheimer’s disease

Project Title: MicroRNA lipid-nanoparticle based therapy targets neuroinflammation and ApoE dysregulation
in Alzheimer’s disease
Abstract
MicroRNAs (miRNA) are small non-coding regulatory RNA that have large impacts in health and disease.
While prior studies have implicated miRNA in Alzheimer’s disease and associated dementias (ADRD), they
have not been used yet in a successful therapeutic strategy. We discovered that microRNA-223 (miR-223), a
miRNA residing on the X-chromosome which is enriched in microglia/macrophage cells, regulates a sexually
dimorphic ApoE pathway via targeting CCAAT-enhancer-binding protein beta (CEBPβ). CEBPβ is an important
regulator of neuroinflammatory response and acts as a transcription factor mediating ApoE expression.
Our recent data showed that deficiency of miR-223 resulted in a substantial, female-biased elevation of
CEBPβ, ApoE, and a heightened inflammatory state in macrophages and in aged mouse brain following a
brain injury. Thus, miR-223 appears to regulate a sexually dimorphic microglia/macrophages-dependent
increase in inflammation and ApoE as brain cells become activated in parallel with age, injury, and/or
Alzheimer’s disease-related pathology. We further demonstrated that miR-223 can be targeted using a novel
miRNA-liposome delivery system. Based on these exciting preliminary results, the main goals of this proposal
are to test the miR-223-CEBPβ pathway in regulating inflammation-triggered ApoE dysregulation in the
biological context of age, sex, and Alzheimer’s disease-relevant brain injury event; and, to test the efficacy of a
novel liposome-miRNA delivery method as a potential therapeutic strategy.
To complete these objectives, we will 1) confirm that miR-223 directly targets the CEBPβ-ApoE pathway in
myeloid cells, and test whether liposome-miR-223 delivery affects this pathway; 2) test the miR-223-CEBPβ-
ApoE pathway using a brain injury mouse model and target the pathway using the liposome miRNA delivery
system in a novel miR-223 knockout mouse; 3) evaluate the miR-223-CEBPβ-ApoE pathway in human cells in
parallel with neuropathological changes of Alzheimer’s disease. These studies will include assessments of
brain tissue from the world-class University of Kentucky Alzheimer’s Disease Center biobank.
Completion of the funded studies will extend our understanding of mechanisms regulating
inflammation/ApoE pathways in the context of sex, aging, and brain injury, ultimately advancing treatments for
Alzheimer’s disease. Filling these knowledge gaps could have a lasting impact on public health. Moreover, our
innovative miRNA-based therapeutic strategy targeting miR-223 provides a proof of efficacy for a new drug
target, particularly in females, who are vulnerable for diseases associated with neuroinflammation and ApoE
dysregulation, including Alzheimer’s disease and other brain injury.

Public health relevance
Project Narrative This project will reveal a novel mechanism regulating a female-biased, neuroinflammation-trigged ApoE dysregulation pathway in the context of sex, aging, and brain injury. Furthermore, this study will provide a proof of efficacy for a new drug target, particularly in females, who are vulnerable for diseases associated with neuroinflammation and ApoE dysregulation, including Alzheimer’s disease and brain injury.